A home-based intervention to improve adherence to the 24-Hour Movement Guidelines in young children

PROJECT SUMMARY
Few
behaviors
inadequate
development,
are
Pitfalls
behaviors
this
movement
child
and
Behavior
of
Finally,
randomized
Hour
didactic,
populations
(Training
and
these
and
candidate
ultimately
young children meet the recently adopted World Health Organization recommendations for movement
(physica activity, sleep, and screen-time), known as the 24-Hour Movement Guidelines. This
balance of movement behaviors places children at risk for more behavioral problems, poor cognitive
delayed motor skills, and obesity. Minority children and children who live in low-income household
at increased risk of meeting ew recommendations, and consequently these long-term health outcomes.
of current literature include focusing on one behavior at a time and neglecting the context in which these
occur. Ecological momentary assessment (EMA) and mHealth tools are ideally positioned to address
gap, by assessing and addressing movement behaviors in real-time and within the home, where all three
behaviors occur. Using mixed methods, this study aims to identify patterns (amount and context) of
movement behaviors within the home via EMA paired with a child-worn accelerometer and identify barriers
facilitators to changing these behaviors within the home via semi-structured interviews (Research Aim 1).
change theory, previous literature, and an iterative process using parent feedback will inform the design
a movement behavior intervention delivered through a mHealth modality e.g., mobile app, Research Aim 2).
this study will then pilot test the preliminary effectiveness and feasibility of this intervention n a
control trial with the goal of meeting all three movement behavior recommendations, t hus the 24-
Movement Guidelines (Research Aim 3). To complement these research aims, the candidate will receive
hands-on, and applied research training i n EMA, mHealth, and interventional research amongst diverse
(Training Aim 1), along with behavior change theory and child behavior and cognitive development
Aim 2). The candidate will expand her network and presence, and scientific prowess in writing grants
mentoring to propel her into a future career as a 24-Hour Movement expert (Training Aim 3). Experts in
respective fields, who are also seasoned mentors, will guide her t hrough these research and training aims,
ultimately into an independen position and research career. This experience will culminate in data for the
to build her independent research program, with the goal of improving child movement behaviors, and
their long-term health.
l
f
(
i
t

Public health relevance
PROJECT NARRATIVE Few behaviors children young children meet the recently dopted World Health Organization recommendations for movement (physical activity, sleep, and screen-time), known as the 24-Hour Movement Guidelines, putting at risk for more behavioral problems, poor cognitive development, delayed motor skills, and obesity. a This study will advance current literature by addressing all three behaviors together and within the setting where all three behaviors occur, the home. This pathway to independence award will combine targeted training, mentorship, and career development, along with a rigorous and innovative methods, to create one of the first 24-Hour Movement Guideline interventions with the goal of improving multiple health behaviors, guideline adherence, and ultimately child mental and physical health.